Forum on Regenerative Medicine

Project Summary
The National Academies’ Forum on Regenerative Medicine brings together leaders from
academia, industry, government, patient and provider organizations, regulators, payers, and
foundations to meet and discuss sensitive and difficult issues in a neutral setting in order to
engage in dialogue and discussions that address the challenges facing the application of and the
opportunities for regenerative medicine to advance the health of the public. The purpose of the
Forum is to explore and identify strategies for advancing the field of regenerative medicine,
facilitate communication and cooperation across stakeholder groups, and facilitate the discovery,
development, and translation of regenerative medicine findings into therapies for medicine,
public health initiatives, education, and policy. The Forum does not provide advice or
recommendations on any specific issue or policy pending before any government agency.
The Forum meets two to three times per year to identify, illuminate, and develop strategies for
collaboratively resolving key issues in the field of regenerative medicine. The Forum holds
public workshops to gain further expertise and perspectives on a given topic, engage the wider
community of stakeholders, and focus public attention on critical issues. Proceedings are
published from each public workshop and disseminated widely via the internet and also in print.
The Forum also encourages and facilitates collaborative efforts among members.

Public health relevance
Project Narrative The National Academies’ Forum on Regenerative Medicine convenes two to three times per year to identify, illuminate, and develop strategies for collaboratively resolving key issues in the field of regenerative medicine in order to advance the health of the public. The Forum fosters communication and cooperation across stakeholders groups and facilitates the discovery, development, and translation of regenerative medicine findings into therapies for medicine, public health initiatives, education, and policy. The Forum holds public workshops to gain further expertise and perspectives on a given topic, engage the wider community of stakeholders in discussion, and focus public attention on critical issues in regenerative medicine.